Surgeon Scientist Training in Cardiac Diseases

ABSTRACT
The goal of this new T32 post-doctoral training grant is to prepare the next generation of exceptional surgeon-
scientists to tackle the most pressing scientific questions in adult and pediatric cardiovascular diseases. Given
the decline in the number of cardiovascular surgeons conducting research, there is a critical need to provide
foundational research training for aspiring cardiothoracic surgeon-scientists to: (1) advance the rigor and
specialty-specific context of cardiac surgical research and policy and (2) establish thought leaders who positively
advance clinical care and outcomes within cardiac surgery. The goal of the Surgeon Scientist Training in Cardiac
Diseases (SSTCD) is to provide cardiac surgery residents with training in basic, translational, and clinical/health
services research to foster their development into independent surgeon-scientists.
The University of Michigan (UM) is uniquely positioned to train promising surgeon-scientists in adult and
pediatric cardiovascular disease research given its extramurally funded cardiac surgery basic, translational, and
clinical/health services research laboratories; Frankel Cardiovascular Center and Congenital Heart Center; and
Institute for Healthcare Policy and Innovation. The SSTCD’s Director (Dr. Chen) and the two Associate-Directors
(Drs. Ailawadi and Likosky) have ongoing funded laboratories examining various aspects of cardiovascular
disease-related conditions across this translational research continuum. We will recruit surgeon-scientist
trainees in the midst of their clinical residency, with each trainee choosing between a basic/translational research
track or a clinical/ health services research track that meets their interests and training needs. Program oversight
will be provided by a Steering Committee (for overall program function), individual trainee Mentoring Committees
(similar to a thesis committee), and an Internal and External Advisory Board. The Program is composed of four
areas: (1) A Mentor-Guided Research Experience - trainees will work on a broad range of basic/translational or
clinical/health services research topics in a collaborative atmosphere; (2) Didactic Training – trainees will learn
life and leadership skills, responsible conduct of research, epidemiology, and cardiovascular biology; (3)
Academic Productivity – trainees will put their training into practice by participating in research seminar series,
presentations at monthly research-in-progress series, an annual departmental “Resident Research Day”,
presentations at national conferences, and peer-reviewed publications and; (4) Program Evaluation – our multi-
faceted approach will ensure that our program meets the evolving needs of future trainees. We expect our new
training program will lead to a cadre of exceptionally trained young surgeon-scientists who will pursue cutting-
edge research to become mentors and leaders in the field.

Public health relevance
PROJECT NARRATIVE This new post-doctoral training program will establish a pipeline to train outstanding surgeon scientists in cardiac surgery. We will leverage the considerable resources at the University of Michigan in medical education; NIH- funded laboratories in basic, translational, and clinical/health services research as well as a talented pool of mentors to attract surgeon scientists during their cardiac surgery residency. Our multi-disciplinary training program for surgeon scientists will prepare them for exceptional careers in cardiac surgery with the ultimate goal of advancing health and health outcomes for patients with cardiovascular diseases.